Core C: Data Management and Statistical Core

The Database Management and Statistics Core provides a secure database infrastructure to support the
acquisition, storage, and transmission of research data generated by the Center, and provides biostatistical
consulting and analysis support to Center investigators and others accessing these data for research
purposes. We maintain a recruitment and operations database used to monitor all contacts with participants
and potential participants in cohort studies and clinical trials. We maintain a secure, web-based, relational
database with PostgreSQL backend and PHP front end for input, storage, and retrieval of clinical and
research data generated by the Center. We use provided web-based tools to support all National Alzheimer’s
Coordinating Center data sharing initiatives. Biostatistics faculty and an M.S. biostatistician provide statistical
consultation and programming support using the statistical programming language R. Graduate students,
post-doctoral appointees, and early stage faculty are mentored in Alzheimer’s disease research and statistical
research methods via hands on collaborative production of manuscripts for peer-reviewed publication.